Understanding the metabolic pathology of pediatric obesity and NAFLD

PROJECT SUMMARY
Nonalcoholic fatty liver disease (NAFLD) is now the most common liver disease worldwide and affects nearly
40% of obese youth and up to 10% of the general pediatric population. Some features of NAFLD are similar in
children and adults, yet fibrosis and inflammation are more common in the portal zone and occur earlier in
pediatric NAFLD patients than adults. This portends a rapid progression to end-stage liver disease in early
adulthood. For the majority of children with NAFLD, mechanisms driving the origin and rapid progression of
disease remain unknown. Thus, there is a critical, unmet need to study the specific underlying patterns of
metabolic and molecular changes in the liver underlying development and progression unique to children with
NAFLD. Hepatic de novo lipogenesis (DNL) is a primary driver of hepatic steatosis in adults with NAFLD and
is accelerated by insulin resistance. Additionally, flux through the TCA cycle toward gluconeogenesis (GNG) is
increased, which promotes mitochondrial damage, liver injury, and progression to nonalcoholic steatohepatitis
(NASH) through oxidative stress. Whether and how elevated rates of DNL and GNG advance pediatric NAFLD
is unknown. MicroRNAs (miRNA) are critical regulators of DNL and GNG in animal models and emerging as
potential biomarkers in adults with NAFLD but are understudied in pediatric NAFLD. Our preliminary data
show that serum miR-122 and miR-192 are increased in adolescent NAFLD patients compared to controls.
However, a complete profile of circulating miRNAs in pediatric NAFLD is now possible to develop a non-
invasive biomarker panel for children. We will combine novel tracer, RNA, and tissue imaging methods to
discriminate the metabolic and molecular changes among clinically-significant stages of pediatric NAFLD. We
hypothesize that increased rates of DNL and GNG are causative pathways for progression from NAFLD in
children, that miR-122 and miR-192 drive the development of steatosis to NASH, and that spatial heterogeneity
in portal zone gene expression, fibrosis, and oxidative activity are responsible for the unique histopathology in
children. In aim 1, an oral tracer approach is used to measure DNL and GNG in adolescents with NAFLD and
in healthy peers who are classified as either obese or normal weight. In aim 2, miRNA analyses in serum and
liver will determine their role as biomarkers for NAFLD and mediators of the disease. In aim 3, we will perform
high resolution molecular imaging of liver biopsies to determine the abundance and distribution of fibrosis,
energetics, and transcripts. This study will establish for the first time whether GNG and DNL drive the
pathogenesis of pediatric NAFLD, whether miRNAs are circulating biomarkers for diagnosis of NAFLD, and
whether the periportal distribution of liver gene expression, oxidative metabolism, and collagen formation
unique to pediatric NAFLD patients are associated with worse metabolic assessments. Collectively, by taking
advantage of unique tools, we will identify the sub-cellular etiology, early mechanisms, and potentially
modifiable pathways and biomarkers unique to children with NAFLD.

Public health relevance
PROJECT NARRATIVE This proposal will test how excess glucose and lipid is produced by the liver in children with pediatric nonalcoholic fatty liver disease (NAFLD), whether those events are regulated by specific variations in the amount and location of RNAs and proteins in liver, and whether the concentration of specific micro-RNAs in the blood can be used as a biomarker for NAFLD in pediatric patients.